Bacterial extracellular vesicles in microbiota-brain communication and hypertension

Project Summary
Disruption of the normal gut microbiota composition, termed gut dysbiosis, is an underlying cause of
hypertension (HT). The pathway where dysbiosis leads to HT involves gut inflammation, neuroinflammation in
the cardiovascular control centers in brain, and ultimately HT. This pathway from gut microbiota to HT requires
communications via the microbiota-gut-brain axis (GBA), a multiple component system for the communication
between the gut and the brain. Although a number of mechanisms have been described as messengers for GBA
communications, our understanding of the GBA in the context of HT is lacking. Extracellular vesicles (EVs)
released from bacteria represent a route for inter-kingdom communication through which the gut microbiota
influences host. In this proposal, we will develop the idea that extracellular vesicles (EVs) derived from gut
microbiota constitute an important component of the GBA communications involved with the development of HT.
We now propose the overall hypothesis that the dysbiotic microbiota releases pro-inflammatory bacterial
EVs that induce gut inflammation, neuroinflammation, and HT. In strong support of this hypothesis, we
demonstrate that the cargo of bacterial EVs isolated from normotensive Wistar Kyoto (WKY) rats and
spontaneously hypertensive stroke prone rats (SHRSP) gut is significantly different. Specifically, the pro-
inflammatory bacterial components flagellin and lipopolysaccharide (LPS) are significantly elevated in SHRSP
EVs. We show that bacterial EVs gain access to blood and brain. Finally, transplantation of bacterial EVs from
SHRSP to WKY by oral gavage leads to increased blood pressure (BP). This proposal will interrogate the role
of bacterial EVs as mediators of the GBA by examining the effects of EVs at the epithelial interface and in brain.
In Aim 1 we will identify the bacterial origin of bacterial EVs involved in the development of HT and examine the
mechanistic role of bacterial EV flagellin and LPS. Using a novel dilution scheme to simplify bacterial
communities, we will determine the bacteria producing EVs that contribute to elevated BP. In Aim 2 we will
elucidate the role of bacterial EVs on gut epithelial inflammation. Using gut enteroids derived from WKY and
SHRSP we will determine the direct effects of bacterial EVs on epithelial inflammation and barrier function. In
Aim 3 we will define the role of bacterial EVs on the development of neuroinflammation. Using single cell RNA
sequencing we will determine the effects of bacterial EVs on microglia and neurons in the paraventricular
nucleus. We will also deplete microglia to investigate the role of neuroinflammation in bacterial EV-induced HT.
The focus of this proposal represents a novel area of investigation examining the role of bacterial EVs in the
GBA and hypertension. These studies represent a translatable foundation for development of novel approaches
for the prevention and treatment of HT.

Public health relevance
Project Narrative Recent studies have shown that disruption of the gut microbiota, known as gut dysbiosis, plays a role in the development of hypertension, which is the leading modifiable risk factor for the development of cardiovascular disease. Understanding the associations between gut dysbiosis and hypertension could result in new and novel therapeutic interventions aimed to alter the gut microbiota and improve blood pressure. The proposed studies will examine a novel mechanism by which gut dysbiosis may contribute to the development of hypertension.